Cancer Center Support (CORE) Grant

PROJECT SUMMARY OVERALL
The mission of The Jackson Laboratory Cancer Center (JAXCC) is to discover precise genomic solutions for
cancer by making basic discoveries with human impact. Committed to our role as a basic research Cancer
Center, we harness our transdisciplinary strengths in complex genetics and functional genomics to achieve this
goal. Organized in a single research program, Genetic models for precision cancer medicine, the 53 full members
combine the JAXCC's unique capabilities to model human cancers in mice with innovations in genomic and
computational analytics of human cancers to attack this broad problem. From RNA biology to chromatin
dynamics, from organismal to in silico models of cancer, from panels of genetically diverse strains to humanized
mice, from single cell genomics to Patient Derived Xenografts, from genomic engineering technologies to
genomic diagnostics—The JAXCC brings advanced technologies to bear on persistent cancer problems through
collaborative partnerships with clinical investigators. Since 2013, we achieved unprecedented growth with 22
new members with expertise in immunology, computational biology, genomic technologies, epigenetics,
microbiome, tumor microenvironment, and clinical genomics. The Shared Resources (Cancer Model
Development Resource, Computational Sciences, Genetic Engineering Technologies, Genome and Single Cell
Technologies, and Phenotyping Technologies) provide comprehensive support for this wide range of research.
The collaborative environment, access to powerful technologies, and our use of Developmental Funds has
yielded significant advances: in the past 5 years, we have more than doubled our funding from NCI and other
cancer agencies and increased our overall intra-programmatic grant collaborative rate from 21% to 47%. Our
translational impact includes development of therapeutics exploiting genomic instability; our role as a discovery
engine for SWOG and our new community cancer genomic education initiative, the Maine Cancer Genomics
Initiative. In the next five years, the JAXCC will harness the collective energy of our expanded Cancer Center.
We will identify origins and the consequences of complex structural genomic alterations in cancer; we will craft
genetically complex models of cancer to uncover the systems biology of the disease; we will explore the cellular
dynamics of primary cancer cells in culture to uncover genetic causes of therapeutic insensitivity; and we will
explore tumor-microenvironment interactions through in vivo and in vitro tissue reconstructions. Our goal in the
next grant cycle is to bring several diagnostics and therapeutics to clinical development. In addition, we will
establish a Cancer Education and Career Enhancement core that supports a continuum of learning for students,
trainees, early career investigators and the Maine community oncology care providers. Our focus on complex
genetics and functional genomics, the scale of our model creation and experimentation, and the integration of
our diverse talents make the JAXCC a unique enterprise.

Public health relevance
PROJECT NARRATIVE OVERALL Genetic complexity and cellular heterogeneity are the greatest challenge to understanding and treating cancer. The Jackson Laboratory Cancer Center is focused on resolving this complexity through applying advanced computational and genomic approaches on novel organismal, cellular, and computational models of cancer, and by investigating the in vivo tumor-stromal-immune interactions. We translate our findings to the clinic through the provision of genetic and genomic technologies to key clinical collaborators.